Brief Mental Health Treatment For Parents of Children with Pediatric Feeding Disorder

PROJECT SUMMARY
Parent mental health (MH) problems are an unaddressed barrier to effective treatment of pediatric feeding
disorder (PFD). PFD affects up to one-third of young children and is characterized by severely restricted volume
or variety of food intake. Many children do not respond to our most effective treatments, and addressing barriers
to effective treatment is critical to improving our ability to treat PFD. Without effective treatment, PFD can lead
to malnutrition and high healthcare utilization. Up to 40% of parents of children with PFD experience mental
health (MH) problems such as depression, anxiety, and parenting stress, which is far greater than rates in parents
of healthy children. Parent MH problems are associated with suboptimal child feeding practices and poor
adherence to treatment recommendations. Positive, non-coercive, parent-child mealtime interactions are
paramount to effective treatment of PFD. However, parent MH problems contribute to increased stress at meals
and parents often report having “battles” with their children over eating, rather than engaging in recommended
strategies. Despite the well-known impact of parent MH problems on effective PFD treatment, it is extremely rare
that parent MH is addressed in PFD care. No MH treatments have been tested with parents of children with PFD,
and there are no universal PFD standards of care to encourage or guide parent MH treatment implementation.
Without identifying an effective and efficient (i.e., brief) MH treatment for parents of children with PFD, our most
effective PFD treatments will continue to fail many children. Focused Acceptance and Commitment Therapy
(FACT) is ideal to address this gap, as it can be effective in just 1-2 sessions. In a recent study of FACT with
parents of children with neurodevelopmental disorders, parent depression and anxiety improved in 2-sessions,
and demonstrated downstream improvements in child behavior. The developers of FACT propose this treatment
effect likely occurs through psychological flexibility, which is associated with adaptive parenting behaviors (e.g.,
positive reinforcement, limit setting). However, the association between parent psychological flexibility and
parent-child mealtime interactions remains untested. The objective of this K23 study is to assess the efficacy of
a 2-session FACT intervention for parents of children with PFD. We hypothesize that FACT-PFD will be effective
in reducing parent MH problems, improving parent psychological flexibility, and improving parent-child mealtime
interactions. The proposed training will focus on clinical trial conduct and analysis, observational behavioral
coding, and implementation science. Results of this project have the potential to identify an effective parent MH
treatment and to launch the independent career of a highly promising junior scientist.

Public health relevance
PROJECT NARRATIVE The proposed project will be the first to study the efficacy of a mental health treatment for parents of children with pediatric feeding disorder (PFD). This intervention uses Focused Acceptance and Commitment Therapy techniques, is tailored to parents of children with PFD, and has the potential to improve parent mental health in just 2 sessions. If successful, this project will result in a highly innovative way to address both parent mental health and child health (e.g., quality of life, feeding behaviors) in pediatric treatment settings.